Development of a Molecular Toolbox for Pneumocystis

Abstract
Pneumocystis jirovecii (Pj) is a fungal pathogen responsible for pneumonia (PjP) in
immunocompromised individuals. Understanding the pathobiology of the organism and its
infection is limited by the inability to cultivate pneumocystis outside the mammalian lung and a
lack of molecular tools that would enable functional studies. The completion of the genomic
sequencing of Pj and the closely related rodent pathogens P. carinii (Pc), and P. murina (Pm)
found in rats and mice respectively, has allowed analysis of the genome and transcriptome under
conditions of infection, however, the Pneumocystis toolbox still lacks tools enabling most
functional rather than descriptive studies. The primary goal of this proposal is to develop a
transformation system through the application of CRISPR/Cas9 gene editing technology and a
plasmid mediated approach to this non-culturable pathogen. During the R61 phase of the
proposal, we will introduce mutations associated with sulfa resistance into the folic acid synthase
gene either by CRISPR/Cas9 gene editing or as a selectable marker on a plasmid introduced into
the organism. We propose using extracellular vesicles (EVs) normally scavenged by Pm as
transporters to introduce Cas9-sgRNA-dDNA or plasmids into Pm organisms. Successful
transformation should manifest as organism proliferation despite the administration of
sulfamethoxazole daily to immunosuppressed mice inoculated with transformed Pm organisms.
In the second phase (R33), these techniques would be applied to demonstrate how these
molecular tools would be used in functional studies addressing the biology and pathogenesis of
Pneumocystis infection. We would demonstrate the utility of gene knock-out and gene knock-in
using CRISPR and recombinant protein expression using plasmid -mediated transformation. This
innovative methodology is poised to facilitate functional studies, by providing new and unique
tools to explore the biology of these host-obligate pathogens.

Public health relevance
Understanding of both the biology of the Pneumocystis jirovecii and the pathogenesis of the pneumonia it causes has been severely limited by the inability to cultivate pneumocystis outside the mammalian lung. The primary goal of this proposal is to develop molecular tools to allow gene editing and overexpression in this non-culturable pathogen. Development of such molecular systems would shift the paradigm of Pneumocystis, making it more accessible and attracting an influx of new investigators into the field to help move research forward at a rapid pace.